Optimizing efficiency and impact of digital health interventions for caregivers: A mixed methods approach

PROJECT SUMMARY/ABSTRACT
One in six American adults provide care for a loved one with disabling illness, and these family caregivers are
more likely to experience insomnia and other psychological concerns than the general population. Multiple
existing, evidence-based digital health interventions may effectively address caregivers' psychosocial needs and
increase caregivers' access to supportive care. For example, Sleep Healthy Using the Internet (SHUTi)
developed by co-I Ritterband is an NCI-designated research-tested intervention that delivers cognitive-
behavioral therapy for insomnia. A key translational research question remains about existing evidence-based
digital health interventions like SHUTi, namely, what level of tailoring would be necessary and sufficient achieve
optimal engagement with and efficacy of these interventions for caregivers? To address this research question,
we will recruit 100 high-intensity caregivers with insomnia to complete a baseline assessment of insomnia and
caregiving context. Caregivers will then receive access to SHUTi in an open-label trial, then complete post-
assessment and be categorized according to their level of engagement with the 6 intervention “Cores”: non-
users (i.e., completed no Cores), incomplete users (i.e., 1 to 3 Cores), and complete users (i.e., 4 to 6 Cores).
For Aim 1, we will test the association of SHUTi engagement with caregiving context. First, we will test whether
caregivers' engagement with SHUTi (i.e., being a non-user vs. incomplete user vs. complete user) is associated
with their user characteristics (i.e., caregiving strain, self-efficacy, and guilt) and environment characteristics (i.e.,
proximity to care recipient; care recipient functional, cognitive, and behavioral status; caregiving tasks; Aim 1a).
Second, we will describe caregivers' barriers to and motivations for SHUTi engagement from their responses to
open-ended surveys, and how caregiver-specific tailoring may improve uptake and usage (Aim 1b). Thematic
coding will also examine how caregivers' recommendations generalize to other evidence-based digital health
interventions, and findings will be validated using synthesized member checking. For Aim 2, we will test whether
the effects of SHUTi on known cognitive mechanisms of change targeted by SHUTi (i.e., more adaptive sleep
beliefs, internalized sleep locus of control) are associated with differences in caregiving-related user and
environment characteristics. Findings from these two aims are not only necessary to direct next research on
tailoring and testing SHUTi for caregivers specifically, but also to advance the science towards our long-term
goal, namely, to improve the quality and impact of digital health interventions for caregivers, while reducing
intervention development inefficiency – a goal identified as a high priority for current caregiving research. As
such, findings will be translatable across research-tested intervention programs and hold significant promise to
reduce inefficiencies in developing digital health interventions for caregivers, while also increasing intervention
impact and reach for this underserved population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because about one in six American adults provide care to a family member with serious illness, and digital health interventions have significant potential to support these caregivers' psychological well-being. Relevant to the missions of NIH and NCATS, the long-term goal of this work is to improve digital health interventions for caregivers by determining what tailoring is needed to improve caregivers' ability to use and benefit from these interventions. Towards this goal, this study proposes a mixed- methods approach to assess how caregiving context relates to engagement with and efficacy of an established digital health intervention that delivers cognitive-behavioral therapy for insomnia.